Allosteric modulators of the PTH/PTHrP receptor

Summary
Disturbances in the maintenance of normal mineral-ion and vitamin D (VitD) balance result in kidney stones, and
osteoporosis and lead to significant and costly pathologies affecting Veterans’ health. To overcome limitations
of teriparatide (PTH1-34) efficacy in the treatment of osteoporosis, this project proposes to test and optimize in
silico identified small non-peptidic molecules (referred to as Pitt molecules) that can act as allosteric modulators
of parathyroid hormone type 1 receptor (PTH1R) signaling as future potential therapeutic candidates for osteo-
porosis and hyperparathyroidism. An interdisciplinary approach has been developed to demonstrate the efficacy
of Pitt molecules in modulating PTH signaling in vitro, and thereby identify small molecules with therapeutic
potential against bone and ion mineral diseases.
The specific Aims of this project are: (1) Small molecule selection. We will characterize pharmacological pro-
files of a series of 22 non-peptidic allosteric modulators in cultured cells expressing the PTH1R to identify the
most effective allosteric small molecules for modulating PTH1R signaling using state-of-the-art optical analysis
of receptor signaling in live cells. The most efficient compounds will be optimized to achieve higher affinity and
efficacy via medicinal chemistry methods. (2) Small molecule validation. The most effective positive and neg-
ative allosteric modulators will be validated by testing their effects on osteoblast via PTHR signaling and miner-
alization. (3) Chemical optimization of small molecules efficacy. Advanced organic chemistry methods will
be applied to refine and optimize the efficacy and potency of selected allosteric modulators of PTH1R function.
The significance of this research program lies in its premise to lay the groundwork for a future translational
research program that examines the therapeutic utility of these Pitt molecules for treatment of osteoporosis.

Public health relevance
Project narrative The goal of this project is to identify novel small molecule modulators of the parathyroid hormone (PTH) type 1 receptor (PTHR) as potential drug candidates, or building blocks, for further optimization for the treatment of hypercalcemia and osteoporosis, highly significant and costly bone and mineral disease affecting Veterans’ health.